Direct from sample whole genome sequencing of Neisseria Gonorrhoeae to reveal patterns of STI epidemic synergy in African populations with high HIV burden

ABSTRACT
There are approximately 82 million incident Neisseria gonorrhoeae (Ng) infections globally each year and the
highest per-capita burden is in Eastern and Southern Africa (ESA). Over half of global incident HIV infections
also occur in ESA and people living with HIV are disproportionately at risk of acquiring Ng infection. Further, a
global increase in multi- and extensively-drug resistant Ng threatens control efforts. Our understanding of Ng
transmission dynamics within ESA, and in particular its interaction with the sexual networks on which HIV is
also transmitting, is limited by a lack of surveillance data from the region, particularly among women and
asymptomatic men. Ng surveillance efforts in ESA are hindered by the need for isolate culturing for
antimicrobial susceptibility testing and whole genome sequencing (WGS). In this proposal, we will develop and
validate direct from sample Ng WGS methods that alleviate the need for isolate culturing. These methods will
be used to generate Ng WGS data from ~250 GC+ penile and vaginal swabs sampled from population-based
STI trials (STIPS and IN-STEP) nested within one of the largest HIV population surveillance cohorts in ESA,
the Rakai Community Cohort Study (RCCS, Uganda). Data generated as part of this study will be used to
provide preliminary insights into the transmission of Ng into- and within-Uganda, the presence of circulating
drug resistant lineages, and the overlap between Ng and HIV transmission networks. This work will support
future expansion of genomic surveillance of Ng and other bacterial sexually transmitted infections (STIs) in the
RCCS and other low-resources regions with high burdens of HIV and non-HIV STIs.

Public health relevance
NARRATIVE Neisseria gonorrhoeae (Ng) is one of the most common sexually transmitted infections and the burden of disease is concentrated in Eastern and Southern Africa (ESA) where there is also a significant burden of prevalent and incident HIV infections. Our knowledge of the epidemiological interaction between HIV and Ng transmission dynamics is hindered by a lack of Ng genomic data from the region, due to the onerous laboratory methods needed to generate these data. In this proposal, we will develop and validate direct from sample Ng whole genome sequencing methods which will be used to provide insight into Ng antimicrobial resistance and the overlap of Ng and HIV transmission dynamics in a high burden region.